Targeting Metastasis Induced by Mesenchymal Stem Cells in the Tumor Stroma

PROJECT SUMMARY/ ABSTRACT Metastasis remains the primary cause of breast cancer-related mortality yet there are no pharmacological inhibitors that target it. Metastatic behavior in breast cancer cells is currently thought to be induced by signals from the tumor microenvironment. Recent advances have shown that bone-marrow derived mesenchymal stem cells (MSCs), that home in to the sites of breast cancer growth in large numbers, promote metastasis in breast cancer cells. The mechanism underlying this was previously shown to be secretion of the chemokine CCL5 by MSCs. However, CCL5 secretion is not increased when some breast cancer cell-lines interact with MSCs even though they become more metastatic, suggesting that alternative mechanisms exist. To identify other mechanisms of metastasis promotion by MSCs, we performed gene expression analyses of MSCs and breast cancer cells after they had interacted in vitro. Network analysis identified type I interferons at the node of the most significant network of genes upregulated by those interactions. We hypothesize that type I interferon signaling is also activated when MSCs interact with breast cancer cells in vivo and this pathway is required for the MSC promotion of metastasis. Our hypothesis is supported by preliminary studies that show that interferon associated genes (IFGs) are highly overexpressed in the stroma of invasive breast cancers compared to normal stroma and outperform CCL5 as discriminators of invasive cancer stroma. Meta-analysis of whole-tumor derived gene expression datasets revealed that 11 IFGs, but not CCL5, are significantly associated with poor survival. Further, knockdown of a key transcription factor of the interferon pathway inhibits MSC-induced breast cancer cell migration in vitro. The major goals of this proposal are to identify the component of the interferon pathway that is the best biomarker of invasive breast cancer stroma, determine if interferon signaling is necessary for MSC-induced metastasis and to identify small-molecule inhibitors of the pathway that could be used as metastasis inhibitors. Biomarkers will be identified by RT-PCR and immunohistochemistry of tumor specimens derived from patients with early stage breast cancer who either did or did not ultimately develop metastasis. The necessity of interferon signaling for MSC-induced metastasis will be determined by knockdown of key components of interferon signaling and studying effects first on MSC- induced breast cancer migration in vitro, then MSC-promoted metastasis in vivo in a NOD-SCID xenograft model. Small-molecule inhibitors will be identified by assembling a collection of novel small molecules that inhibit regulators of the interferon pathway, determining if any of them inhibits the expression of the key components identified in previous aims then measuring effects on MSC-induced breast cancer cell migration in vitro. In the future, the best small molecule will undergo optimization and pharmacokinetic characterization prior to in vivo testing. The proposed studies are ideally suited for my goal of transitioning into an academic physician-scientist specialized in small-molecule inhibitors of the breast cancer microenvironment.

Public health relevance
PROJECT NARRATIVE The purpose of this grant application is to support my career development activities towards a highly trained independent physician-scientist. Metastasis is the major cause of death from breast cancer and with the mentorship of experts of the field I will undergo training and conduct research on how breast cancer cells acquire metastatic properties under the influence of certain non-cancerous cells that surround them. We will also investigate whether that metastatic acquisition can be blocked by targeted chemicals opening the possibility of developing drugs against breast cancer metastasis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The majority of the approximately 500,000 deaths annually1 from non-hematological cancers in the United States are attributable to metastasis but there are currently no pharmacological inhibitors of metastasis. Recent advances have indicated that bone marrow derived mesenchymal stem cells (MSCs), that home in to the sites of tumor growth in large numbers2, promote breast cancer metastasis3. While the chemokine CCL5 secreted by MSCs has been found to be a mechanism of metastasis-promotion, CCL5 secretion is not always elevated during MSC-induced metastasis3, suggesting that alternative mechanisms exist. To systematically identify regulators of MSC-induced metastasis, gene expression profiles were constructed to understand the changes that occur when MSCs interact with the breast cancer cell-line MDA-MB-231 (MDA) in vitro. Using network analysis the type I interferon network was identified as being the most significant change induced by those heterotypic interactions. Interferon gene expression signatures have previously been correlated with metastasis in breast cancer patients4-6 and the same transcription factors regulate the expression of both type I interferons (IFN) and CCL57. We therefore hypothesize that type I Aim 3 interferon signaling is activated when mesenchymal stem cells ? interact with breast cancer cells in vivo and is required for the CH H 3 promotion of metastasis that follows these interactions. H C O O ¿migration 3 O Preliminary studies indicate that knock-down of IRF7, a central Aim 2 ? ¿metastasis regulator of this pathway8, inhibits MSC-induced MDA cell migration MDA in vitro. We find that IFN associated genes (IFG) are highly expressed in stroma of invasive breast cancer patients. Meta-analysis of 20 ? datasets (comprising >3000 patients) that correlated gene expression Aim 1 ¿IFG MSC of whole breast tumors with survival revealed 11 IFGs that are significantly associated with poor survival. Specific aims to address the hypothesis are: Aim 1: Determine whether interferon associated genes discriminate the stroma of high vs. low metastatic tumors in vivo using human breast cancer samples. Of the IFGs upregulated in MSCs, 43 are highly expressed in human tumor stroma and of these, 11 IFGs are associated with poor survival in whole-tumor microarray studies. Confirmation that the stromal expression of these IFGs is associated with metastasis will be achieved by quantifying (i) mRNA expression: stroma of human breast tumors with metastasis will be compared with tumors Figure 1. Hypothesis: Interactions of stromal MSCs with breast cancer cells (MDA) increase expression of IFGs in MSCs which is required for metastasis. Aim1 evaluates if increased expression of IFGs occurs in metastatic stroma in vivo; Aim2 assesses if inhibiting IFG expression with RNAi blocks metastasis; Aim3 determines if decreasing IFG expression with small molecules inhibits metastatic behavior. without metastasis using laser capture microdissection and RT-PCR; (ii) protein expression: tissue microarrays (TMA) will be constructed on a single slide using tumor blocks from a training set of 93 patients and immunohistochemistry (IHC) will be performed on that slide against IFGs validated to have elevated mRNA expression. Quantification will be done using the Allred score which has been clinically validated for the quantification of estrogen receptor IHC9-11. Predictive value of IFGs will then be determined in a separate testing set TMA of 239 tumor blocks from 79 patients with and 160 patients without metastasis12. These studies will develop robust IHC stromal biomarkers that predict metastasis in breast cancer patients. Aim 2: Determine whether activation of the interferon pathway is required for MSC-promoted metastasis. IFGs found to be upregulated in MSCs and key IFN pathway components will be investigated by 2 approaches: (i)in vitro: lentiviral RNAi knockdown of those genes in MDA-MSC co-cultures and measuring effects on cell migration using a 'wound-healing' assay; (ii)in vivo: IFGs that affect cell migration in vitro will be stably knocked down in MSCs, which will be co-injected with luciferase labeled MDA cells into NOD-SCID mice and metastasis will be measured. This will indicate that the IFN pathway is not just a marker but a necessary mechanism of MSC-induced metastasis and will identify the IFG which has the greatest impact on metastasis. Aim 3: Evaluate whether small-molecule modulation of interferon genes required for metastasis could inhibit MSC-induced metastatic behavior. We have assembled a collection of small-molecule inhibitors of various components of the IFN pathway which could modulate the expression of IFGs. Compounds will be tested for effects on (i)mRNA expression of the IFG identified as necessary for MSC-induced metastasis in Aim 2; (ii) migration of MDA cells induced by MSCs using the in vitro wound-healing assay. These studies will determine whether small-molecule probes of the IFN pathway block metastatic behavior and will pave the way for more optimal small-molecule development against the IFN pathway and metastasis in the future.